Core C Immunophenotyping

The goals of the COBRE Center for Applied Immunology and Pathological Processes are to establish a nationally
recognized advanced research and training program in immunology and inflammation and to facilitate the development
of junior faculty research programs to achieve major independent research funding. High capacity multi-analytical
flow cytometry and microscopy are critical research tools for immunological studies, however, generating
high quality, reproducible data requires extensive expertise in protocol development. The development of
Core C, the Immunophenotyping Core, will serve as a Shared Resource Laboratory by providing COBRE
investigators access to technical expertise to take advantage of existing state-of-the-art immunophenotyping
technology currently available at Louisiana State University Health Science Center-Shreveport. Core C personnel
will have expertise in a range of experimental techniques in the field of immunophenotyping such as multianalyte
extracellular and intracellular flow cytometry, multi-analyte bead arrays, super-resolution fluorescent immunohistochemistry
and in situ hybridizations. Core C personnel will work closely with COBRE investigators to
optimize experimental design, develop immunophenotyping protocol, execute immunophenotyping experiments,
and analyze data. Thus, Core C will be a conduit between COBRE PI laboratories and the LSUHSC-S Research
Core Facility, allowing these laboratories to extend their research into the fields of immunology, inflammation
and infectious disease more quickly than if these labs attempted to perform these techniques themselves. The
development of Core C will advance individual COBRE investigators projects while enhancing infrastructure of
local immunology and inflammation research, thus benefiting the whole institution.